NRSA Training Core

The Institute of Translational Health Sciences (ITHS) TL1 training program has a long history of preparing
University of Washington (UW) predoctoral investigators to become successful translational scientists. Since
2007, 131 individuals have completed the yearlong program and over 90% are still engaged in research or
training. The experience brings together trainees from a broad range of scientific disciplines and varied expertise.
Cohort-based learning emphasizes collaboration and teamwork, skills critical to interdisciplinary research. The
curriculum, based on nationally developed translational science competencies, uses interactive educational
methods that encourage trainees to think independently, and provides a shared learning experience rich in real-
world examples of how translational science is conducted. Trainees complete a translational research project
under the supervision of mentors from ITHS partner institutions and are guided by an individualized career
development plan created with their mentor(s) and TL1 Program Directors, who are themselves experienced
translational investigators. In the next 5 years, the ITHS TL1 program will be augmented in 2 significant ways:
1. Enhance the existing educational program through brief real-world practicums across the
translational phases of development, demonstration, and dissemination. Trainees will select practicum
opportunities such as participating in ITHS service consultations on research projects or following the
development of an IRB protocol or intellectual property disclosure. Options will be tailored to trainees’
backgrounds, experience in related competencies, and career plans. Experiences will enhance translational
science skills by helping trainees see classroom concepts in practice, exposing them to more disciplines and
approaches, and observing an interdisciplinary team in action.
2. Adapt the UW TL1 program for the 5-state Washington, Wyoming, Alaska, Montana, and Idaho region
by establishing a TL1 cohort at Montana State University using a collaborative, hybrid educational
model. Montana State is a robust academic research institution supported by substantial federal funding with
programs in rural health equity, rural and tribal populations, and emerging infectious diseases. The proposed
cohort brings together 12 TL1 predoctoral trainees at UW and 6 at Montana State in a bi-directional, joint training
effort. Trainees will be linked via a virtual online learning platform, with faculty and staff from both sites offering
training content in their respective areas of expertise. This expansion builds on existing and emerging
collaborations between both institutions with experienced staff, directors, and resources needed to successfully
train the next generation of translational research scientists.
The established TL1 curriculum will ensure continued quality and rigor in training for all students, while the
proposed new aims will reinforce learning through real-world application and expand training strengths and
experiences through collaboration between UW and Montana State University faculty and students.